Developing Systemic in vivo Massively Parallel Reporter Assay to Elucidate the Genetic Etiology of Problematic Alcohol Use

Abstract
Problematic alcohol use (PAU), a complex phenotype that combines alcohol use disorder (AUD) and alcohol-
related problems identified by a survey (AUDIT-P), is a major public health issue that arises from intricate
interactions between genetic and environmental mechanisms. Genome-wide association studies (GWAS) have
identified genomic regions associated with PAU, but it is difficult to determine which genomic variants functionally
contribute to the development of PAU, largely because many of these variants are located in the noncoding
genome. Recent advances in high-throughput sequencing technologies now permit the functional
characterization of thousands of noncoding, disease-associated variants simultaneously with massively parallel
reporter assays (MPRA). However, MPRA studies have traditionally been conducted in vitro which limits our
ability to identify tissue- and sex-specific variant effects. Because the regulatory genome is sensitive to factors
like cell state, tissue type, and environmental perturbation, it is crucial to study the regulatory function of
noncoding variants within the intact physiological context.
The goal of this project is to identify which PAU risk variants alter transcriptional regulatory capacity in the intact
brain and liver under natural physiological conditions and to determine whether this modulation will differ in
response to ethanol exposure. To determine the regulatory activity of variants in a tissue- and sex-specific
manner, I will perform in vivo MPRA via intracerebroventricular and systemic tail vein injections (Aim 1). I will
then perturb the animals with acute or chronic ethanol administration via intraperitoneal injection which may
induce variant regulatory activity that is not present in the homeostatic state (Aim 2). The results of this work will
pinpoint the putatively causal PAU-associated variants in a tissue- and sex-specific manner as well as which
variants exhibit functional regulatory activity only in the environmentally perturbed state. Successful completion
of this project will positively contribute to the neurogenetics field by determining which variants should be pursued
for further study within their natural genomic context, thus elucidating the underlying molecular mechanisms of
genetic predisposition for PAU.

Public health relevance
Project Narrative Although problematic alcohol use (PAU) is a major public health concern, there are only three approved pharmacological treatments due to the condition’s complexity which is influenced by genetic predispositions and environmental exposures. The proposed research will identify which common genetic variants functionally contribute to the development of PAU. The results of this study will increase our understanding of the genetic etiology underlying PAU and will determine which genes should be pursued as potential treatment targets.